System to Allow Off Site Monitoring of Pressure Ulcers for Patients in a Rural Long-Term Care Facility

Abstract
This phase I will show the feasibility of an imaging instrument to assist an individual caregiver in monitoring
deep pressure tissue injuries (DPTIs). Patients that are immobile, are insensate, choose to not move can
develop pressure ulcers (PUs). These PUs should be examined for their skin integrity on a frequent basis.
This project will develop a system to allow an untrained caregiver to collect visual and thermal images that
provide remote wound assessment. The capture of both visual and thermal images provides the benefit of
wound assessment for patients with different skin tones including darkly pigmented skin. For the individual
caregiver the practical process of obtaining a digital image is very difficult because they normally would use
both hands to reposition the patient to get a good field-of-view of the PU. In low-income rural nursing homes
with minimal staff, they may not have the ability to both position a patient into a natural light setting and to
operate the camera. The innovation is to combine a very miniature thermal image camera and visible image
camera on a low-cost head mounted display. This will allow one caregiver to position the patient, aim the
imager and acquire the new image of the PU for remote assessment. A smartphone connected with the head-
mounted display would send the images to a wound specialist for the remote clinical assessment.

Public health relevance
Project Narrative Pressure ulcers (PU), affect approximately 2.5 million people in the United States and cost the American healthcare system more than $11.6 billion annually. Pressure ulcers cause significant pain to affected patients, damage patients’ skin integrity, and cause life threatening infections. More than 60,000 PU-related deaths occur in the United States each year. Pressure ulcers and their adverse effects are more common in the long- term care (LTC) setting than other healthcare settings primarily because the majority of people admitted to LTC usually have limited or no mobility, compromised health conditions, and multiple diagnoses which make them high risk for the development of PUs.